Statistical Models and Mechanisms Linking Biomarkers of Aging to Cognitive-Physical Decline and Dementia

Dementia affects over 44 million adults worldwide, and Alzheimer’s disease (AD) and related dementias
(ADRD) account for 60%-80% of all cases among older adults. Physical disability is often the final
consequence of dementia before death. One-third of dementia cases may be attributable to modifiable factors,
and due to unclear benefit of AD treatments, there is a need to identify intervention targets to prevent dementia
and physical disability. Since both conditions may be preceded by poor cognitive and physical performance by
over a decade, shared biological determinants of dual cognitive-physical decline that impact neurological and
musculoskeletal systems may inform therapeutic targets to prevent dementia and physical disability. The
geroscience hypothesis posits that targeting the biology of aging may better impact human health, including
prevention of dementia and physical disability, than targeting specific diseases. Indeed, separate lines of
research on cognitive and physical endpoints indicate that biomarkers reflecting the underlying biology of aging
are related to both cognitive and physical decline. This work includes biomarkers of inflammation and
hallmarks of aging such as cell senescence, altered cell communication, epigenetic changes, telomere attrition,
nutrient signaling, and loss of proteostasis. However, epidemiologic studies have not rigorously investigated
whether biological mechanisms of aging affect relations and dynamics between cognitive and physical decline
or dementia and physical disability onset. Thus, identifying early biomarkers of biological aging mechanisms
that are related to dual cognitive-physical decline and joint dementia-disability onset in initially health older
adults is a key step toward geroscience-guided prevention trials. However, studies of longitudinal cognitive and
physical endpoints are vulnerable to survival bias and unmeasured confounding. Limitations of extant statistical
methods are a key barrier to accurately identifying biomarkers of shared biological mechanisms that may affect
or predict cognitive and physical endpoints. Thus, new computational models are needed to overcome these
barriers. Specific aims of this proposal are to: 1) test relations of biomarkers of aging with longitudinal dual
cognitive-physical decline; 2) test relations of biomarkers of aging with time to incident joint dementia-disability
onset; and 3) develop/validate a biomarker of aging risk score to predict joint dementia-disability. To this end,
we propose a biological aging index and novel computational models for multivariate longitudinal and time-to-
event outcomes and to apply them to harmonized data from 8 cohort studies of >11,000 community-dwelling
adults aged at least 65 years with measured biomarkers. We hypothesize that biomarkers of aging predict and
explain, in part, relations between cognitive and physical endpoints beyond known risk factors. New computa-
tional models developed as essential tools to jointly study cognitive and physical endpoints will be shared with
the scientific community. The ultimate public health impact of this project is new models and novel biomarkers
of aging to inform new geroscience-guided strategies to prevent ADRD and physical disability in older adults.

Public health relevance
The over 44 million persons worldwide living with dementia are primarily older adults with Alzheimer’s Disease (AD) or related dementias (ADRD). The consequences of physical disability and death from AD combined with uncertain clinical benefit of AD treatments motivate the search for targets of preventive intervention. We hypothesize that biomarkers of aging are related to cognitive and physical decline long before dementia and physical disability and are the source of modifiable biological mechanisms; thus, we propose to harmonize data from over 11,000 older adults with measured biomarkers to develop and disseminate computational models to identify potential biological aging-related targets of intervention to prevent ADRD and physical disability.